Novel Role of Thrombospondin-1 in Protection against Rupture of Abdominal Aortic Aneurysm

Abdominal aortic aneurysm (AAA) is the progressive weakening and dilation of the aorta. A substantial
knowledge gap exists in the understanding of molecular mechanisms responsible for aneurysm rupture, the
major cause of mortality among AAA patients. Following our prior report of elevated thrombospondin-1 (TSP1)
in human and mouse aneurysmal tissues, we conducted single-cell RNA sequencing (scRNA-seq) analysis and
identified macrophages (Mɸs) being the primary source of elevated TSP1 in mouse aneurysmal aorta. We
subsequently generated Mɸ-specific Thbs1 knockout mice (Thbs1∆Mɸ) by crossing Lyz2-Cre with our newly
constructed Thbs1flox/flox mice. When subjected to aneurysm induction by angiotensin II (Ang II) coupled with
hypercholesterolemia, over 60% of Thbs1∆Mɸ died due to AAA rupture, an incidence that was 2.6 times higher
than Thbs1wt. Intriguingly, Thbs1∆Mɸ mice that survived to the end of 28-day Ang II infusion showed less aneurysm
dilation than Thbs1wt. Smaller aneurysmal expansion was also found when Thbs1∆Mɸ mice were challenged with
perivascular application of CaCl2, an AAA model that does not produce rupture. We propose two specific aims
to delineate the mechanisms through which Mɸ-specific Thbs1 gene deletion differentially affects aortic
dilation and rupture with an emphasis on AAA rupture. Specific Aim 1 devotes to establishing the rupture-
preventive function of Mɸ TSP1. Specifically, we will determine the aortic responses proceeding lethal rupture in
male and female Thbs1∆Mɸ mice in the Ang II model followed by identifying rupture-associated molecular
signatures through scRNA-seq, in situ hybridization and immunostaining. Furthermore, we will examine the
effects of Mɸ-specific Thbs1 knockout using a different murine model that produces rupture in advanced stages
of aneurysm, which is more relevant to human AAA than the early rupture produced by the Ang II model. Specific
Aim 2 focuses on investigating molecular mechanisms of aneurysm rupture. Preliminary studies showed that
compared to wildtype, Thbs1-/- Mɸs had significantly reduced ability to migrate or to engulf apoptotic cells as well
as neutrophil extracellular traps (NETs). We will test whether Mɸ TSP1 promotes NET clearance through CD47-
mediated actin polymerization. Next, we will establish the causal effect of impaired Mɸ migration and
phagocytosis on aneurysm rupture of Thbs1∆Mɸ mice. We will first determine whether NET burden is increased
in Thbs1∆Mɸ died from rupture, and the spatial relationship between NETs and Mɸs. Second, we will test whether
restoring Mɸ migration in Thbs1∆Mɸ reduces NET accumulation via adoptive transfer strategies. Furthermore, we
will examine whether enhancing or attenuating NET clearance affect aneurysm rupture in Thbs1∆Mɸ. Lastly, we
will analyze TSP1 expression and its association with Mɸ and NET accumulation in ruptured and non-ruptured
human AAA tissues. By dissecting the multifaceted functions of Mɸs through TSP1 manipulations, this project
will produce significant impact on the understanding of aneurysm rupture.

Public health relevance
PROJECT NARRATIVE Abdominal aortic aneurysm is a major vascular disease in the United States, but current treatment relies on detection, monitoring, lifestyle changes, and surgery. Very little is known about the molecular mechanisms contributing to aneurysm rupture, a highly lethal complication among aneurysm patients. The proposed research aims to investigate how thrombospondin-1 coordinates the vascular responses that drive or protect aneurysm growth and rupture, which will facility therapeutic development for aortic aneurysm.